The impact of clinical interventions for sepsis in routine care and among detailed patient subgroups: A novel approach for causal effect estimation in electronic health record data

Sepsis causes an estimated one in five deaths globally, including approximately 190,000 deaths per year in the
United States. Given the complexity and heterogeneity of the condition, a “one-size-fits-all” approach to sepsis
care, which is largely the approach taken by clinical guidelines, is unlikely to be most effective. Yet, it is not
feasible to conduct a randomized controlled trial (RCT) among each patient subgroup that can be formed from
the hundreds of possible combinations of important sociodemographic (e.g., age group) and clinical (e.g.,
comorbidities or cause of sepsis) characteristics of patients. Observational studies in electronic health record
(EHR) data could circumvent this feasibility constraint thanks to the large size and “real-life” representativeness
of EHR data. However, such observational studies have the critical disadvantage that they are thought to
merely yield associations rather than causal effect estimates, because they make the untestable and frequently
implausible assumption that all confounders were perfectly measured and adjusted for in the analysis. The
objective of this New Innovator Award is to develop and test a new study design for clinical research on sepsis
– machine-learning-facilitated regression discontinuity (ML-facilitated RD) – that would allow researchers to
determine causal effects for common sepsis care interventions in large-scale EHR data without needing to rely
on confounder adjustment. ML-facilitated RD combines machine learning with a novel causal inference
technique (regression discontinuity) to improve the robustness of the technique for causal effect estimation, its
ability to reliably determine causal effects for each of a large number of highly granular patient subgroups, and
to ascertain the optimal threshold in continuous variables (e.g., in mean arterial pressure) at which the
intervention of interest should be initiated in each patient subgroup. We will additionally develop RD such that it
can be applied to the multi-factorial decisions that are common in clinical care for sepsis. This project has two
steps. In the first step, we will develop these methodological innovations with the aid of extensive simulation
exercises. In the second step, we will test the feasibility and validity of ML-facilitated RD for each of 12
common clinical interventions for sepsis in each of 15 EHR datasets from a variety of clinical settings. The key
innovation of this project is that it aims to establish a study design for EHR data on sepsis that uses a
fundamentally different approach for causal effect estimation than current state-of-the-art methods. By
providing a new tool to clinical researchers for determining the causal effects of clinical interventions for sepsis
in routine care and among highly granular patient subgroups (including which threshold in continuous clinical
measurements is optimal for initiating these interventions in each subgroup), this research would constitute a
major step forwards in individualizing care for sepsis. It would also establish an important foundation for further
methodological innovation and adaptation to allow ML-facilitated RD in EHR data and similar causal inference
approaches to be used in other areas of clinical medicine.

Public health relevance
PROJECT NARRATIVE Combining a novel causal inference method with several statistical and machine-learning techniques, this New Innovator Award will develop and test a new study design for determining the causal effects of clinical interventions for sepsis in large-scale electronic health record data. If successful, this project will equip clinical sepsis researchers with a tool that uses a fundamentally different approach to causal effect estimation than current state-of-the-art methods, to reliably determine the effectiveness of clinical interventions for sepsis in routine care. This study design would constitute an important step towards providing more individualized care for sepsis because it would allow clinical researchers to take advantage of the large size of electronic health record data to establish how the effectiveness of different interventions for sepsis varies across highly granular patient subgroups defined by various combinations of sociodemographic and clinical characteristics.